Core--Technical Facility

The core will provide support for administrative and technical personnel who are vital to the success of the three components of AADRC. In addition, it will provide funds to maintain the FACSCalibur, a piece of equipment that is that are vital to AADRC investigators. The Principal Investigator will ensure that the AADRC functions in a cohesive integrated fashion. He will interact with the research grant administrators at the NIH, Children s Hospital and Harvard School of Public Health to administer the grant. The technical part of the core will serve the FACS analysis needs of the projects and will breed maintain the transgenic mice shared between projects.